Role of organelle dynamics and retrograde signaling during plant innate immunity

1 Project Summary
2 This project focuses on the chloroplast as central player in the generation of immune signals and the
3 regulation of programmed cell death (PCD) required for innate immune responses against pathogen infection.
4 Although mitochondria play a central role during mammalian PCD, emerging evidence suggests that in plants
5 chloroplasts have a critical function in executing localized PCD that limits pathogen spread. Chloroplasts in
6 addition to being involved in the generation of immune signals, such as reactive oxygen species (ROS) and the
7 defense hormone salicylic acid (SA), also participate directly in the recognition of pathogens. Interestingly,
8 chloroplasts dynamically change their morphology during immune responses and send out stroma-filled tubular
9 projections called stromules. These induced stromules use the cytoskeleton to extend and then anchor to the
10 nucleus, which facilitate perinuclear clustering of chloroplasts and transport of chloroplast-generated hydrogen
11 peroxide (H2O2) ROS and defense proteins to the nucleus. The overall goal of this application is to use a
12 combination of novel cell biology, genetics, proteomics and computational approaches to unravel the
13 mechanistic basis of stromule formation and their role in driving perinuclear chloroplast clustering and
14 subsequent release of retrograde immune signals from chloroplasts to nuclei. Specifically, Aim 1 will identify
15 and characterize proteins required for stromule formation and stromule-directed chloroplast movement. This
16 includes the kinesin motor required for extension and proteins associated with the outer envelope of stromules
17 that may drive stromule initiation or regulation. An unbiased forward genetic screen will be conducted to
18 identify other stromule specific components. Aim 2 will investigate immune signals required for stromule
19 induction and the release of H2O2 as a specific retrograded chloroplast signal. The role of stromules in
20 amplification of immune signaling consisting of SA and H2O2 signaling will be examined. The relationship of
21 different H2O2 sources, organelle movement and PCD during immune responses will be studied to determine
22 how H2O2 propagates extracellularly to intracellular sources to regulate innate immune responses. The function
23 of stromules and chloroplast positioning during H2O2 signal propagation will be examined using the stromule-
24 specific mutants characterized in Aim 1. Aim 3 will focus on how pathogen effectors affect stromules,
25 organelle, and cytoskeleton dynamics as a virulence strategy. In addition, mechanistic basis of how three
26 effectors disrupt stromules and organelle dynamics will be determined. Understanding the role of different
27 organelles during PCD and innate immunity will provide a unified mechanistic basis of cell death and cell
28 survival process that occur in response to infectious pathogens. The results from our model systems will
29 impact broadly on understanding of organelle-to-nuclear communication that influence innate immunity against
30 infectious diseases.

Public health relevance
Project Narrative The proposed research will provide new insights into how organelles dynamically change, release retrograde signals, and ultimately communicate to rapidly respond to prevent infectious diseases, and how pathogens target organelle dynamics as a virulence strategy.